Role of metabolic Me-macrophages in the pathogenesis of tuberculosis during diabetes

ABSTRACT The type 2 diabetes mellitus (T2D) pandemic is a recognized re-emerging risk and challenge to tuberculosis (TB) control. However, strategies to identify and prevent the millions of T2D patients at risk of developing TB requires an understanding of the underlying mechanisms, which are poorly understood. Mycobacterium tuberculosis (Mtb) is an intracellular pathogen that can replicate or get killed within macrophages (MΦs). The ability of Mtb to survive within MΦs depends largely on its ability to evade fusion of the Mtb-containing phagosomes with lysosomes or auto-phagosomes (autophagy pathway). However, in-vitro studies show that with appropriate MΦ activation (e.g. with IFN-γ), intracellular Mtb is targeted to the phagolysosome or auto- phagolysosome for more effective killing, digestion and antigen presentation to T cells. Studies of human MΦ phenotype and function are often conceptualized through an M1 and M2 paradigm, with the M1 characterized by increased production of pro-inflammatory cytokines, while M2 having more immunosuppressive phenotype. We and others have used the M1/M2 paradigm to study TB pathogenesis, with M1 MΦs exerting better Mtb killing when compared to the more permissive M2 (M1> M2). While the M1-M2 MΦ framework has been useful to study TB pathogenesis in-vitro, it does not capture the different environmental cues that influence MΦ plasticity in the T2D host. We address this gap by proposing the development of an in-vitro model to study TB pathogenesis in T2D patients using a recently described MΦ phenotype that is polarized to a “metabolic” phenotype when cultured under conditions of high palmitate, glucose and insulin. We propose studies using this Metabolic MΦs (Me) to determine how the altered metabolic environment in T2D patients affects the phenotype and functional responses of MΦs to Mtb (vs M1 or M2). Our team is ideal conduct these studies: BIR (MPI) lives in the Texas-Mexico border where she has demonstrated high TB-T2D rates, and documented defects in monocytes and MΦs from T2D patients. CJ (MPI) has 30+ yrs experience in MΦ responses to TB. Our consultants developed the Me MΦ model (LB), or have expertise in TB lung biology (JT). Our Aims are: Aim 1. Evaluate the response to Mtb by human Me MΦs differentiated under controlled culture conditions that simulate T2D in the lungs. Aim 2. Identify differences in the Me MΦs derived from monocytes of healthy vs T2D +/- TB patients. Our in-vitro TB-T2D MΦ model will retro-feed with in-vivo findings in T2D or TB-T2D patients or animal models, facilitating hypothesis generation and testing. Our access to monocytes from patients with TB or T2D will help identify the “metabolic” or “inflammatory” memories in vitro, that are retained after chronic exposure to altered metabolites in-vivo. Thus, our model will have an immediate impact for paving the design of effective host- directed therapies to polarize human diabetic MΦs for optimal Mtb killing.

Public health relevance
Narrative Type 2 diabetes mellitus (T2D) is rapidly becoming one of the most pressing human health problems in the world. The mechanism by which T2D compromises the ability of the human immune system to response to tuberculosis (TB) has remained poorly understood for decades. We will capitalize on a population with severe health disparities and high rates of T2D and TB, to define defects in the ability of human white blood cells to kill the TB bacterium.